Structural and Molecular Phenotyping of Embryonic Development through Multi-Modal Optical Imaging

PROJECT SUMMARY
The ability to correlate between large-scale developmental milestones and micro-scale cellular and protein-
specific changes is a significant unmet need in the study of developmental biology. The overall objective of this
work is to develop a multi-modality imaging platform that can provide time resolved three-dimensional images
of tissue development, with high temporal and spatial resolutions at a molecular level.
Current studies rely on multiple imaging modalities to collect information on critical stages of vertebrate
embryogenesis, and most offer only static snapshots of a single developmental stage. Live imaging with optical
coherence tomography (OCT) provides high temporal resolution with contrast between tissue structures,
allowing researchers to identify and test the mechanisms underlying developmental processes. Three-
dimensional fluorescence approaches such as confocal and light sheet microscopy (LSM) provide increased
resolution and molecular specificity which can be used to observe cellular mechanisms, such as the presence
of erythroblasts indicating active blood flow, that are inaccessible to lower-resolution techniques.
This will be accomplished by designing and developing a novel microscopic imaging system that provides
spatially and temporally aligned OCT and light sheet microscopy images. Simultaneous images will be collected
through OCT scanning and fluorescent light sheet excitation of the same sample plane. Fluorescence emission
will be imaged through a second objective, while the OCT signal will be collected through the same lens in
reflection mode. Software will be designed to synchronize data collection with an integrated high-precision
rotational stage. A novel software toolkit will be developed to analyze this rich multi-modal data. Novel
reconstruction methods will be designed to fuse both modalities, while addressing the sparse and multiplex
nature of the LSM images and high frame rate of OCT. Finally, we'll use this tool to test the central hypothesis
that a combined LSM+OCT imaging system can reveal the precise structural and molecular events required
to form a circulatory loop between the embryo and maternal chorio-allantoic placenta. Successful
accomplishment of the proposed work will generate a novel, integrated imaging platform, including
instrumentation and analytical software, which could be widely adopted by developmental biologists to bridge
the gap between large-scale developing phenotypes and the underlying molecular and cellular processes. We
will benchmark this accomplishment by identifying currently unknown critical milestones in murine embryonic
development. Specifically, LSM+OCT will be used to define the precise series of events necessary to form the
umbilical artery (UA) and umbilical vein (UV). This research will clarify the sequence of events, including cellular,
molecular, and global phenotypic changes, that lead to the establishment of an embryonic circulatory system
between the mother and developing fetus, a critical prerequisite for embryonic survival.

Public health relevance
PROJECT NARRATIVE We propose to create the first multimodal optical coherence tomography and light sheet imaging platform to examine embryonic vascular development in mammalian models. This combined approach will provide tremendous utility for characterizing complex biological activities that exhibit structural and molecular changes at the organismal, tissue and cellular levels. This research is relevant to public health because it will allow us to quantify events in murine embryonic development that directly translate to human clinical disorders that cannot be studied in vivo using current singular imaging modalities or in vitro cell-based assays.